Role of exosomal SPHK1 in ovarian cancer progression

PROJECT SUMMARY
Immunotherapies, including those that involve immune checkpoint inhibitors against programmed death-ligand
1 (PD-L1) and programmed death-1 (PD-1), have revolutionized cancer treatment. However, in stark contrast to
other malignancies such as melanoma or renal cell cancer, immunotherapies against ovarian cancer have been
largely ineffective. Sphingosine kinase 1 (SPHK1) appears to dysregulate key pathways important for anti-tumor
immune responsiveness in ovarian cancer and several lines of evidence may explain the minimal success of an
immunotherapy approach. Elevated levels of sphingosine-1-phosphate (S1P) in ovarian cancer blood samples,
compared to normal subjects, have been previously observed. We also unexpectedly found that SPHK1
co-localized and associated with extracellular vesicle (EV) proteins in ovarian cancer cells. Furthermore, we also
have data suggesting extracellular S1P signaling activates PD-L1 expression and inhibits cytotoxic T cell action.
Encouraging immune cells to recognize and attack cancer cells is essential to develop an immunotherapy
against ovarian cancer and requires a detailed understanding of how SPHK1-packaged EV dysregulates
immune response in the tumor microenvironment, for which little is known.
This proposal seeks to test the central hypothesis that tumor cells employ EVs to deliver SPHK1 to the tumor
microenvironment, facilitating extracellular S1P maturation. Subsequent S1P signaling promotes
E2F1-mediated transcription of PD-L1, causing immune suppression and tumor proliferation. We will assess this
model by performing the following three specific aims: (1) Dissect the molecular mechanisms underlying SPHK1
packaging into extracellular vesicles and their effect on extracellular S1P maturation. (2) Delineate the
mechanism whereby S1P signaling promotes immune cell inactivation in ovarian cancer. (3) Define the role of
SPHK1-packaged extracellular vesicles in ovarian cancer progression.
We expect this project will elucidate a novel mechanism by which S1P and SPHK1 promote immune evasion by
high-grade serous ovarian cancer cells. We also anticipate that these studies will determine whether SPHK1 or
S1P can serve as predictive biomarkers for immunotherapy targets PD-L1/PD-1 proteins. Furthermore, we
expect SPHK1 inhibition will lower PD-L1 levels and synergize PD-1 blockade for making immunotherapy
possible for ovarian cancer.

Public health relevance
PROJECT NARRATIVE While immunotherapies have transformed cancer treatment strategies, a robust response has not been observed in ovarian cancer. Our studies are geared towards understanding how manipulating sphingosine-1-phosphate (S1P) signaling influences PD-L1 expression, which can be used to produce a favorable immune microenvironment amenable for ovarian cancer immunotherapy.